Indiana Clinical and Translational Sciences Institute

Contact PD/PI: Shekhar, Anantha
INDIANA CLINICAL AND TRANSLATIONAL SCIENCES INSTITUTE: OVERALL
SUMMARY/ABSTRACT
The Indiana Clinical and Translational Sciences Institute (Indiana CTSI) was created in 2008 as a statewide
laboratory to accelerate clinical and translational research by the three research universities, Indiana, Purdue
and Notre Dame, with partner health care systems, local foundations and corporate partners. The mission of
the Indiana CTSI is to serve as the statewide catalyst for translational research and improve human health
across Indiana, the nation and beyond. The Indiana CTSI fosters a collaborative research environment,
provides resources and services to conduct the highest-quality clinical and translational research, offers
education and training programs to build a robust translational workforce, engages our community as a partner
at all levels, and functions as an exemplary member of the national CTSA network. The principle of continuous
innovation cycle of “4Ds”: Design, Demonstrate, Duplicate, and Disseminate guides the Indiana CTSI. The
CTSI plans to accomplish its mission through five Specific Aims: Aim I. Expand education and training to build
a broader array of translational workforce through its Career development, Education and Research Training
(CERT) and related suite of programs. Aim II. Build on the robust Indiana translational research environment
of collaboration and engagement with its outstanding Community Health Partnership (CHeP) program and its
public-private partnerships throughout the state and beyond. Aim III. Further, strengthen the CTSI’s
integrated approach to support translational research across all phases and many scientific disciplines through
its Project Development Teams (PDTs), and include a wide variety of populations across the lifespan. Aim IV.
Promote scientific approaches to design and implement the best methods and processes that accelerate the
transit of ideas and health interventions across the translational stages to reach patients faster. Aim V.
Expand on the exceptional capabilities of the Indiana Translational Informatics Program (iTIP). During the next
5 years, the Indiana CTSI 3.0 will not only expand translational research across the state, but also address
some of the major community health issues faced by Indiana and the nation. In this section, we first describe
the transformative impact the Indiana CTSI has had on the local environment, and outline how it is poised to
make greater impact locally and contribute to NCATS’s mission as an ideal Hub in the national CTSA network.
Frequently used abbreviations: All IN – All Indiana Health & Research; CERT – Career development,
Education and Research Training; CHeP – Community Health Partnerships; CTR – Clinical & Translational
Research; EC – Executive Council; iTIP – Indiana Translational Informatics Program; IUB– Indiana
University, Bloomington; IUPUI – Indiana University–Purdue University Indianapolis; IU Health – Indiana
University Health hospitals; IUSM – Indiana University School of Medicine; ND – University of Notre Dame;
PDT – Project development team; PEC – Patient Engagement Core; PU – Purdue University; RKS –
Regulatory Knowledge and Support; SERVE – Subject Engagement and Research Volunteer Enrollment.
Project Summary/Abstract Page 704
Contact PD/PI: Shekhar, Anantha

Public health relevance
PROJECT NARRATIVE The Indiana CTSI 3.0 will not only expand translational research across the state, but also address some of the major community health issues faced by Indiana, and the nation. We will find novel approaches to integrating `precision medicine' and `population health', embrace the vision to train a new breed of research workforce skilled in team science and community engagement, and both deepen and expand the integration of research in our health systems. Project Narrative Page 705